Role of acid sphingomyelinase in the modulation of coagulation after traumatic brain injury

Project Summary
Alterations in the coagulation profile after trauma are associated with venous thromboembolic events and
subsequent morbidity after traumatic brain injury. Platelet hyperaggregration and microparticle generation
play a role in the development of this ongoing coagulopathy. Acid sphingomyelinase activity may contribute
to both platelet function and microparticle production. Our preliminary data have demonstrated that
traumatic brain injury results in time-dependent changes in platelet aggregation, acid sphingomyelinase
activity, ceramide concentration, and subsequent generation of hypercoagulable platelet-derived
microparticles.The overall goal of this proposal is to demonstrate that changes in acid sphingomyelinase
activity alter platelet function and microparticle generation, leading to hypercoagulability and
thromboembolic risk after traumatic brain injury, with the following aims: Aim 1: Elucidate acid
sphingomyelinase-dependent factors driving arachidonic acid-induced changes in platelet function following
traumatic brain injury. Aim 2: Determine the role of acid sphingomyelinase in modulating platelet-derived
microparticle generation and function after stimulation by proinflammatory factors released by traumatic
brain injury. Aim 3: Determine how acid sphingomyelinase activity regulates traumatic brain injury-induced
platelet-derived microparticle and/or platelet endothelial activation. Successful completion of these aims
may lead to novel therapies to reduce posttraumatic thromboembolic events.

Public health relevance
Project Narrative The dynamic changes in coagulation after traumatic brain injury contribute to clinically significant and persistent morbidity. We propose to elucidate the underlying mechanisms of posttraumatic hypercoagulability in order to reduce the detrimental effects of pathologic clot formation and organ dysfunction. Data from these studies will not only provide new insights into coagulation regulation, but also allow for novel therapeutic targets to reduce post-injury thromboembolic events.